A new and non-autonomous role of androgen signaling in prostate tumorigenesis

Project Summary
Androgen signaling, mediated through the androgen receptor (AR) and androgens, plays a central role
in prostate tumorigenesis. Over the past decades, significant effort has been devoted to determining the
intrinsic mechanism underlying AR action in prostate tumor cells. Androgen deprivation therapy (ADT), directly
targeting AR-expressing prostate tumor cells fails in most prostate cancer patients who consequently develop
castration resistant prostate cancer (CRPC), an incurable disease. Therefore, the role of AR in prostate
tumorigenesis needs to be re-evaluated for designing effective therapeutic strategies.
A non-autonomous role of androgen signaling pathways in prostate cancer tumorigenesis has been
identified recently. Emerging evidence has shown that aberrant AR activation in prostatic stroma promotes
prostate epithelial oncogenesis and tumor formation. Moreover, recent studies further demonstrated that
prostatic tumor stroma supports androgen independence and hormone refractoriness during prostate cancer
progression. However, the underlying mechanisms by which stromal AR facilitates oncogenic transformation of
prostate epithelial cells through paracrine interactions between prostatic epithelium and stroma remain largely
elusive. Specifically, the cellular properties of the stromal cells that can convey androgen signaling to regulate
prostatic epithelial oncogenesis are largely unclear. Recently, we demonstrated a tumor niche role of stromal
AR signaling in Gli1-expressing cells in promoting prostate epithelial oncogenesis and tumor development.
Single-cell RNA sequencing and other experimental analyses showed robust increased expression of insulin-
like growth factor binding protein 3 (IGFBP3) in prostatic stromal AR-null Gli1-lineage cells, which reduces
IGF1 secretion, lessens ligand-induced IGF1R activation, and impairs Wnt/β-catenin-induced prostatic
epithelial oncogenesis in adjacent basal epithelial cells. These data implicate a new and non-autonomous role
of androgen signaling in prostatic Gli1-lineage cells acting as tumor niches to support prostate epithelial
tumorigenesis. In this study, we propose a series of rigorous experiments to test our central hypothesis that the
non-autonomous AR action in prostatic Shh-responsive Gli1-lineage cells promotes prostate epithelial
oncogenesis, tumor initiation, progression, and CRPC development. The proposed studies are expected to
break new ground in many aspects regarding stromal androgen signaling in prostate tumorigenesis.
Successful completion of the proposed study should lead to the development of new therapeutic strategies for
treating advanced prostate cancer.

Public health relevance
Project Narrative Prostate cancer is the third leading cause of death in men in the United States, and nearly all patients treated with androgen deprivation therapy eventually develop castration resistant prostate cancer, which lacks curative therapy. To address this urgent need for developing new prostate cancer therapies, we will test our scientific hypothesis that the non-autonomous AR action in prostatic stromal tumor niche cells promotes prostate epithelial oncogenesis, tumor initiation, progression, and CRPC development. Successful completion of this proposed study will directly impact the current paradigms and lead to the development of new therapeutic strategies for co-targeting both prostate epithelial tumor cells and stromal tumor niches to treat advanced prostate cancer.